TRIAL COMPARING HOE 901 &NPH HUMAN INSULIN SUBJECTS W/ TYPE I DIABET

The primary objective of the study is to compare the safety and efficacy of HOE 901 insulin to that of Human NPH insulin when used with insulin lispro.